FOX CORE Phase II Research Core #1 Analytical

Project Summary
Analytical Core
The Analytical Chemistry Core Facility will consist of instrumentation and infrastructure for molecular
characterization through use of Mass Spectrometry (MS), Nuclear Magnetic Resonance (NMR) spectroscopy,
and a suite of instruments that compose our Kinetics Laboratory. The instrumentation in the core was used
extensively by Phase I investigators, and these instruments will continue to be used in Phase II by researchers
across the IDeA network and beyond. The goals of the Analytical Chemistry Core are (1) development of an
administrative framework for the Analytical Chemistry Core Facility, (2) development of the COBRE-supported
Mass Spectrometry Laboratory, (3) development of the COBRE-supported Solution NMR Laboratory, and (4)
development of the Kinetics Laboratory for monitoring chemical and biological reactions and for measuring
molecular and biomolecular interactions. A plan is described for management, user training and sustainable
support for the broad range of instrumentation throughout the core facility.